Neuromuscular response to competing ACL surgeries

ABSTRACT
The overall project objective is to leverage patients enrolled in the BEAR-MOON Trial to evaluate a
neuromuscular mechanism that may explain differences in functional outcomes between the novel
bridge-enhanced anterior cruciate ligament restoration (BEAR) and the standard of care, anterior
cruciate ligament reconstruction surgery (ACLR). Whereas ACLR requires removal of the injured
ligament and the bony insertion sites to implant a tendon graft, BEAR uses a scaffold to promote healing of
the injured ACL. Therefore, the ACL neural structures and bony insertions remain intact with BEAR, while
they are severed and removed during ACLR. Early clinical studies have shown that muscle strength is
restored following BEAR, but not after ACLR at 2-year follow-up. We have data to show that joint motion
abnormalities similarly persist over a decade after ACLR, which are thought to be a risk factor for
posttraumatic osteoarthritis. Therefore, we postulate that differences in muscle recovery and joint motion
are due to the preservation of neuromuscular function with BEAR. The BEAR-MOON Trial (the parent
study) is a multicenter, randomized control trial comparing 2-year outcomes of BEAR to those of ACLR.
While the parent study will establish whether differences exist between procedures, it was not designed to
determine the mechanism behind those differences. Therefore, the overarching ancillary study hypothesis is
that BEAR preserves the neuromuscular activation patterns about the knee that, in turn, promote normal
hop landing joint motion compared to ACLR at 2 years post-surgery. The ancillary study addresses three
aims: 1) to apply our innovative machine learning approach to classify neuromuscular activity patterns as
belonging to ACLR, BEAR or healthy control subjects (Controls); 2) to compare knee position between
ACLR, BEAR, and Controls at ground contact when landing from a 1-leg hop; and 3) to determine the
relationship between neuromuscular activity patterns and joint motion abnormalities. Twenty-six subjects
enrolled in the BEAR-MOON Trial at Rhode Island Hospital will be recruited into the ancillary study at their
2-year parent study follow-up visit. An age- and sex-matched control group will be recruited from the
community. All 39 subjects will perform a 1-leg hop-for-distance activity while surface electromyography is
recorded to assess neuromuscular function (Aim 1), and biplane videoradiography will be performed to
evaluate precise tibiofemoral motion (Aim 2). Regression analysis will be used to relate neuromuscular
activation patterns with tibiofemoral position (Aim 3). The ancillary study dovetails well with the parent study,
which is now in its final year of recruitment. If the hypotheses of the ancillary study are supported, the
results will demonstrate that ACL mechanoreceptor continuity is the mechanism governing neuromuscular
function, and that its loss with ACLR is a driver of joint motion dysfunction and possible downstream joint
arthrosis that can be explored in future longitudinal studies.

Public health relevance
PROJECT NARRATIVE A new ligament surgery that stimulates the anterior cruciate ligament (ACL) to heal has shown promise in reducing post-surgical posttraumatic osteoarthritis. We believe the reason behind this is that the new surgery restores the native ACL and its neural elements that normally provide information about joint function to the central nervous system, while conventional surgery does not. The parent randomized clinical trial will tell us whether the new surgery is at least as good as the conventional one, and the ancillary study will tell us whether, and how, the new surgery restores muscle and joint function.